Histidine Phosphorylation in Mammals: Regulation, Protein Targets, and Biology

Project Summary
Whereas phosphorylation of serine, threonine and tyrosine are exceedingly well characterized, relatively
little is known about phosphorylation of histidine (His), which may account for as much as ~6% of all incorporation
of phosphate into mammalian proteins. We have provided genetic and biochemical evidence that the histidine
kinase, NDPK-B, and the histidine phosphatases (PTases), PHPT1 and (PGAM5, regulate the activity of the
Ca2+-activated K+ channel KCa3.1 by reversible His phosphorylation, and thereby the activation of CD4 T and
mast cells. While NDPK-B His phosphorylates and activates KCa3.1, PGAM5 and PHPT1 inhibit KCa3.1 His
phosphorylation by specifically dephosphorylating and inhibiting NDPK-B and KCa3.1 respectively. Using
recently developed monoclonal antibodies to 1- and 3-phospho-Histidine (pHis), we demonstrate for the first time
the regulation of histidine phosphorylation in vivo in mammalian cells, which we in turn linked to TCR signaling.
SA1 we will build on these studies, we will assess changes in His phosphorylation of NDPK-B and KCa3.1 in the
context of TCR signaling, determine how it is regulated by various signaling molecules such as PI3KC2, whether
other pHis proteins are present in T cells and/or regulated by TCR signaling, and the specific role for PGAM5,
PHPT1 and NDPK-B to modulate changes in pHis proteins. We have found that the 24 cleaved PGAM5-L
isoform is most critical to dephosphorylate NDPK-B. We will determine whether the 24 cleaved PGAM5-L
isoform negatively regulates CD4 T cells in vivo, whether the amount of this isoform changes following TCR
stimulation, and the intramembranous proteases that mediates cleavage in CD4 T cells.
We also identified a critical role for histidine phosphorylation in pancreatic  cell function. We found that
 cells from PHPT1-/- mice have electrical properties similar to those of patients with mutations in KATP channel
subunits and KATP channel-/- mice. The defect in PHPT1-/- β cells can be explained by the failure of KATP channels
to relocalize from an intracellular compartment to the plasma membrane (PM) in response to low glucose and
leptin and we have now linked the defect in PHPT1-/- β cells to impaired activation of transient receptor potential
channel 4 (TRPC4). Our hypothesis is that reversible His phosphorylation of TRPC4 by PHPT1, NDPK-B,
PGAM5 regulates TRPC4 channel activity in a similar manner to KCa3.1, albeit in opposite directions; whereas
His phosphorylation of KCa3.1 activates, His phosphorylation of TRPC4 inhibits. In SA 2, we will determine if
PHPT1, NDPK-B, and PGAM5 regulate His phosphorylation of TRPC4 in a manner similar to KCa3.1, their role
in KATP channel trafficking and TRPC4 activation, and whether decreased KATP trafficking to the PM in TRPC4-/-
and PGAM5-/- mice leads congenital hyperinsulinemia hypoglycemia that is similar to PHPT-/- mice and patients
with CHI. We will then extend these studies to human  cells and assess the potential relevance of these
molecules to human disease that include CHI and type 2 diabetes mellitus.

Public health relevance
Project Narrative My lab has shown that signals mediated by histidine phosphorylation, of which little was known in mammals, play critical roles in immune T cell and mast cell activation and inhibiting this pathway may be beneficial to treat autoimmune disease and allergy and activating this pathway may enhance anti-tumor immunity. In addition, we have found these new signaling pathways function in pancreatic  cells and have added important insight into how glucose stimulated release from pancreatic  cells is regulated under normal physiological conditions and how dysregulation of these pathways may contribute to diseases such as congenital hyperinsulinemic hypoglycemia of the newborn and diabetes. Building on our previous studies together with newly developed reagents, this proposal will uncover new and fundamental ways histidine phosphorylation regulates immune and metabolic functions.